Attitudes toward influenza vaccination and vaccine uptake among rural adolescents

[unreadable] DESCRIPTION (provided by investigator): This study proposes collection of survey data from students investigating adolescent attitudes and beliefs toward influenza vaccinations as an ancillary supplement to an existing study, "Influenza Vaccine Delivery to Adolescents: Two Multicomponent Interventions." This study will complement the Parent Study by examining whether the relationship between a school-based influenza vaccination intervention and receipt of influenza vaccination is mediated by adolescent attitudes and beliefs toward influenza vaccination. The aims of this study follow a traditional four step mediation analysis, delineated by Barron and Kenny [33]. Steps 1-4 include determining: 1) the relationship between intervention condition and receipt of influenza vaccination; 2) the relationship between intervention condition and change in adolescent attitudes and beliefs toward influenza vaccination; 3) the relationship between change in adolescent attitudes and beliefs toward influenza vaccination and receipt of influenza vaccination; and 4) whether the relationship between intervention condition and receipt of influenza vaccination is mediated by adolescent attitudes and beliefs toward influenza vaccination. Step 1 will be determined by the Parent Study and Steps 2 - 4 will be conducted by this study. The proposed study will recruit 1290 rural adolescents who attend middle- or high school in Warren County, GA or Wilkes County, GA. Prior to receiving the school-based intervention, eligible participants will complete surveys regarding their attitudes and beliefs toward influenza vaccination. At 6 months post intervention, participants will again complete the survey. This study aims to provide valuable information which can be used inform future influenza vaccination interventions among rural adolescents. [unreadable] [unreadable] [unreadable] [unreadable]

Public health relevance
Project Narrative This study proposes to collect survey data from rural adolescents regarding attitudes and beliefs toward influenza vaccination. This study will investigate whether adolescent attitudes and beliefs toward influenza vaccination mediate the relationship between a school-based influenza vaccination intervention and receipt of influenza vaccination among rural adolescents.